Centralized assay datasets for modelling support of small drug discovery organizations

Project Summary We have recently used computational models to identify the protease inhibitor indinavir (used as an antiviral for HIV) as a positive allosteric modulator at the α7-nicotinic acetylcholine receptor. We now propose to build on this discovery as well as other publications describing compounds that are positive allosteric modulators of the α7- nicotinic acetylcholine receptor. We propose identifying further compounds that possess activity against this or one of 9 other targets implicated in Alzheimer’s disease using a combination of Bayesian machine learning and in vitro assays. Generating such data will enable us to potentially provide more specific compounds as well as building datasets that can be used to build predictive models to identify additional compounds with activity at these Alzheimer’s targets. These combined efforts should in the first instance provide commercially viable treatments which will be used to experimentally validate our computational models that can be shared with the Alzheimer’s disease scientific community. We are proposing to build and validate models based on public databases, select compounds for testing and use the data generated as a starting point for further optimization.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is one of the most common neurodegenerative disorders that causes dementia and it is characterized by amyloid deposition of a 39-42 AA peptide (Aβ) processed from the amyloid precursor protein (APP) and neurofibrillary tangles (NFT). Many palliative drugs are available for the disease but there is still an urgent need for curative drugs with greater efficacy. We need to understand the key factors involved in disease progression and their suitability as drug targets for discovering new drugs against Alzheimer's disease. We hence propose to study several of these targets for Alzheimer’s disease involving all the key steps in the pathway, including several old and new targets. We will use our ‘Assay Central’ software to compile structure-activity data for building computational models, that can be used to selected compounds to test activity in vitro as a starting point for further optimization.